Building Academic Advancement research training Pathway to Otolaryngology and Communication Sciences (BAA-POCS)

The disciplines of Otolaryngology and Communication Sciences face persistent challenges in workforce representation despite projected substantial growth in demand over the coming decade. Contributing factors include constrained training pathways, geographic disparities in provider distribution, and a rising need for services driven by an aging population. In Otolaryngology, the deficit primarily reflects restricted training capacity and workforce supply, whereas in Audiology and Speech-Language Pathology, both limited pipeline growth and rapidly increasing demand contribute to the imbalance. Consequently, there is an urgent need to enhance research training and expand workforce capacity in these fields to meet evolving clinical and public health needs. Our proposed Program – Building Academic Advancement research training Pathway to Otolaryngology and Communication Sciences (BAA-POCS) – will address the ongoing workforce shortage and enhance patient access, healthcare outcomes, and clinical research capacity in these disciplines by providing undergraduate students with a rigorous 15-month research training program, alongside exposure to clinical care and community-based health engagement. To achieve our objective, the following specific aims are proposed: [1] Conduct a rigorous research training curriculum for preparing undergraduate students for research careers in Otolaryngology and the Communication Sciences; [2] Provide professional development activities to promote professional identity and preparation for graduate or medical school; and [3] Create support groups for students and program alums to engage one another regarding career decisions. The culmination of this BAA-POCS program will provide students with a comprehensive research training and mentorship experience, which will generate enthusiasm and self-efficacy, and increase the number of students interested in pursuing careers in Otolaryngology and/or the Communication Sciences.

Public health relevance
Otolaryngology and Communication Sciences face critical workforce shortages amid rising demand. The Duke Building Academic Advancement research training Pathway to Otolaryngology and Communication Sciences (BAA-POCS) program will help build future clinical and research capacity by engaging undergraduate students in a 15-month curriculum that integrates research training, clinical exposure, and community-based health engagement.